Pulmonary Vascular Pruning on Computed Tomography and Interstitial Lung Disease Outcomes

PROJECT SUMMARY/ABSTRACT
The interstitial lung diseases (ILD) are a major source of respiratory morbidity, and as a group are the
leading indication for lung transplantation worldwide. Two particularly devastating ILD complications are
progressive lung fibrosis (Progressive ILD) and ILD-related pulmonary hypertension (ILD-PH). While effective
treatments are now available for both types of complications, there is a critical need to identify at-risk patients
before complications have already occurred and treatments become less effective.
A known feature of pulmonary vascular disease is relative loss of the smaller vessels, referred to as
“pruning,” and vascular abnormalities are linked to both Progressive ILD and ILD-PH. Using advanced image
analysis of computed tomography (CT) scans, pruning can be quantified using existing imaging data – since
virtually all patients with ILD undergo CT scanning at the time of diagnosis, this could potentially lead to
widespread improvements in ILD risk stratification.
The key focus of this project is to determine if pruning on CT can identify those at risk for Progressive
ILD and ILD-PH. This study will use both existing data from a cohort of highly characterized patients with ILD
from a sub-specialty clinic, and will also recruit a new prospective cohort to collect follow-up data related to ILD
outcomes. This proposal will combine advanced quantitative image analysis tools, rigorous epidemiologic
methods, and a comprehensive set of ILD-related outcome measures, including lung function testing, CT
imaging, exercise testing, survey scores, hemodynamic assessment, and review of clinical outcomes such as
hospitalization and death. The results of this study will help determine if CT pruning is a non-invasive marker of
high-risk ILD – which may potentially facilitate earlier and better treatment of ILD complications, thus
preventing morbidity and contributing to better long-term health for people with ILD.
During this project, the candidate will develop advanced proficiency with quantitative vascular image
analysis techniques, learn critical new methodological skills, and obtain hands-on experience in the design and
execution of prospective studies. The candidate will be mentored by an outstanding, multidisciplinary team of
experts who will provide rigorous training, complemented by formal coursework, and personalized career
development support. The project takes place within an exceptional and unique institutional environment, and
leverages resources from the Beth Israel Deaconess Medical Center, Harvard Chan School of Public Health,
Applied Chest Imaging Laboratory at Brigham and Women’s Hospital, and Harvard Catalyst. The data, training,
and career development opportunities provided by this award will position the candidate to be a leader and
independent investigator in the application of chest imaging tools that will inform and improve the clinical care
of individuals with chronic lung disease.

Public health relevance
PROJECT NARRATIVE This project will evaluate whether advanced analysis of the pulmonary blood vessels on chest imaging can identify individuals who are at risk for complications related to interstitial lung disease. These results may help physicians recognize which patients with interstitial lung disease would benefit from earlier treatment and may prevent certain severe complications from developing – an important step to improving the long-term health of people living with this chronic lung disease.